Research Career Scientist Award

Sarah L. Krein, PhD, RN has an active and productive research career that builds on her clinical background
as a nurse, her multidisciplinary health services research training (with concentrations in health economics,
research methods and epidemiology), and her interest and expertise in the use of qualitative methods and
implementation research. While creating evidence to improve clinical care and patient outcomes is the general
objective of most research studies, how best to move important research findings into clinical practice is also a
critical area of investigation for ensuring safe, high-quality care for Veterans. As such, collaborating in team-
based science and applying mixed methods and implementation research techniques to better understand and
ultimately improve healthcare safety, quality, and effectiveness have been a consistent theme of her research
for nearly two decades. As a VA research career scientist, Dr. Krein has maintained a robust research portfolio
serving as a principal investigator on at least 1-2 studies and co-investigator/team scientist on 10-12 additional
studies at any given time. Her research is supported through VA grant funding as well as funding from several
other federal and non-federal sources and includes collaborating with local VA and university colleagues as
well as researchers and partners across the VA healthcare system. This includes studies that involve large-
scale implementation of patient safety practices, mixed methods studies of disease transmission, provider
communication, and hospital resuscitation care, as well as trials of novel approaches for managing chronic
pain. She disseminates the findings from these studies through a variety of sources and for both scientific and
non-scientific audiences. Dr. Krein also uses her methodological expertise and diverse content knowledge, as
an active mentor of both clinician and non-clinician scientists, thus supporting a new generation of researchers
as they learn to apply different research methods and embark on research studies to advance care delivery
and patient health outcomes. Moreover, she engages in a range of service opportunities that allow her to use
her expertise and research experience to contribute to the broader scientific community as well as support the
VA research, education and care delivery missions. The senior research career scientist award will allow her to
continue to use her clinical, content and methodological expertise to: 1) obtain funding, conduct, publish and
disseminate high-quality research; 2) train/mentor early career investigators; 3) work with colleagues and
collaborators across the U.S.; and 4) serve on VA committees (local and national) to support VA research and
care delivery.

Public health relevance
Sarah L. Krein, PhD, RN is an active and productive health services and nurse researcher. She uses her clinical knowledge and research expertise to conduct and collaborate on studies to improve healthcare safety, quality, and effectiveness as well as Veteran health outcomes. She also works with clinician and non-clinician scientists who are beginning their research careers, assisting them in learning new research skills and supporting them as they move on to leading their own research studies. The support provided by the VA senior research career scientist award will allow her to continue to use her research expertise and experience to continue conducting research that improves VA healthcare delivery and patient safety, educate new researchers, work with local, national and international collaborators and contribute to activities that support the VA research, education and care delivery missions.